Shear Stress and Endothelial Pathophysiology in Intracranial Atherosclerosis

PROJECT SUMMARY/ABSTRACT
The overall goal of this proposed renewal is to establish that the focal region of low shear stress (0-4 dyne/cm2)
immediately downstream or in the post-stenotic segment of intracranial atherosclerotic disease (ICAD) is a
marker of atherogenesis and recurrent stroke, providing a therapeutic target for anti-inflammatory or anti-
thrombotic interventions. Our central hypothesis is that post-stenotic low shear stress associated with
atherogenic endothelial pathophysiology provides a rational basis for precision medicine of ICAD. Our prior
data on low shear stress in the MCA in SAMMPRIS confirms the potential influential role of shear stress
associated with endothelial pathophysiology recognized in systemic atherosclerosis yet extended to the cerebral
circulation for the first time. Our three expanded independent specific aims leverage an ongoing, invaluable
collaboration and the unmatched quality of the SAMMPRIS imaging archive. The Neurovascular Imaging
Research Core at UCLA will conduct the prospective experiments to validate focal low shear stress measured on
CTA CFD of ICAD across all arteries in SAMMPRIS with detailed anatomical flow models created from the
same source images [SA-1]. This aim enables us to use our validated flow models to directly observe flow
vortices and adjacent low shear stress in all ICAD arterial sites [SA-1]. These validated flow models serve as a
scaffold for endothelium, where the cell morphology, expression of VCAM-1 and platelet aggregation can be
studied in all ICAD locations [SA-2]. The clinical relevance of post-stenotic low shear stress (0-4 dyne/cm2) in
these arterial lesions will be corroborated by imaging adjudication of stroke in the downstream territory after
initial treatment in SAMMPRIS [SA-3]. Associations of this clearly defined potential therapeutic target of
post-stenotic low shear stress will be examined with respect to all arterial sites and treatment methods in
SAMMPRIS [SA-3]. All image post-processing, CTA and DSA CFD, 3D printing, and biological assays of
endothelial pathophysiology will be conducted at UCLA, where we have pioneered this workflow. The ongoing
multidisciplinary enthusiasm of SAMMPRIS trial leadership is an important element of this new approach to
ICAD that employs our collaborative work and publications of these landmark trials and their detailed imaging
and clinical analyses. Our extensive prior work reflecting collaborative multidisciplinary expertise on a novel
imaging and biological framework, coupled with intensive experience linking the SAMMPRIS imaging and
clinical datasets, provide a logical extension of knowledge on atherogenic low shear stress into the cerebral
circulation.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE TO PUBLIC HEALTH STATEMENT This study on the role of Shear Stress and Endothelial Pathophysiology in Intracranial Atherosclerosis uses neuroimaging tests routinely performed in patients with symptomatic intracranial atherosclerosis to validate and establish how mechanical forces on the vessel wall are associated with cellular changes of inflammation and clotting that lead to recurrent stroke. These imaging and biological markers create a new way to prevent such strokes, a leading cause of death and adult disability worldwide. These collaborative efforts that combine unique and established expertise are urgently needed to address the lack of proven invasive or noninvasive imaging tools or treatments for intracranial atherosclerosis and the unmet risk of recurrent stroke.